GLUCOSE RECYCLING IN CANCER CACHEXIA

To develop stable isotope method for the estimation of true glucose carbon recycling and glucose oxidation. To examine the relationship between abnormalities in glucose and amino acid metabolism in cancer cachexia.